Defining Trajectories of Loneliness in Young Autistic Adults

PROJECT ABSTRACT
The proposed longitudinal cohort study aims to understand the development of loneliness and social isolation
among autistic young adults, focusing on the impact of social disruptions such as life transitions during young
adulthood. Despite the growing concerns over loneliness affecting 27%-40% of young adults globally, very little
is known about how changes such as shifts in service systems, employment status, educational transitions, and
residential mobility impact the social connectedness and wellbeing of autistic young adults. Examining the
projective and risk factors contributing to or mitigating the impact of social disruptions on loneliness is a critical
starting point for developing effective intervention and implementation strategies. Young adulthood is a pivotal
yet challenging phase for autistic individuals, marked by frequent social disruptions and diminished opportunities
for meaningful social interactions. Unlike their neurotypical peers, autistic young adults face the layered
challenges of navigating crucial life choices, such as employment, education, and social relationships, against a
backdrop of losing familiar social structures and support systems previously provided by education settings.
Moreover, this life stage often involves increased encounters with neurotypical-majority groups, where
experiences of nonacceptance and misunderstanding can exacerbate feelings of disconnection, presenting
unique social challenges. Our study will enroll 375 autistic young adults aged 18-30 who are approaching
significant life transitions (e.g., starting a new job, entering college, or losing services. Over the course of two
years, we will characterize the trajectories of loneliness and social isolation associated with these social
disruptions, using latent growth mixture modeling to identify distinct subgroups and assess demographic
variations. Then we will evaluate the association between changes in loneliness and social isolation and a range
of adult outcomes, including social, health, and psychological dimensions. Using a mixed-method approach, we
will delve into protective and risk factors—structural, interpersonal, and social—that influence the impact of social
disruptions on loneliness, using both quantitative data and in-depth qualitative interviews to gain a
comprehensive understanding of these dynamics. Guided by the meaningful interaction framework and insights
from autistic community partners, the completion of this study will result in the most substantial work to date to
identify modifiable interpersonal, system, and policy factors to mitigate the impact of social disruptions. This will
inform targeted interventions and improve service delivery, enhancing the quality of life and wellbeing of young
autistic adults and addressing a pressing public health need.

Public health relevance
PROJECT NARRATIVE Despite the growing concerns over loneliness affecting 27%-40% of young adults globally, very little is known about how changes such as shifts in service systems, employment status, educational transitions, and residential mobility impact the social connectedness and wellbeing of autistic young adults. Our proposed longitudinal cohort study aims to track the loneliness experiences of autistic young adults aged 18-30 over two years, investigate its predictability on health and psychological outcomes, and identify protective and risk factors that influence the contribution of social disruptions to loneliness using a mixed method. Guided by the Meaningful Interaction Framework and insights from autistic community partners, the completion of this study will result in the most substantial work to date to identify modifiable interpersonal, system, and policy factors to mitigate the impact of social disruptions on the development of loneliness during young adulthood.